Research Training in Sensorimotor Neurorehabilitation

Project Summary
The goal of this proposal is to implement a novel Research Training in Sensorimotor Neurorehabilitation
program to prepare the next generation of scientists that can address the growing need for neuroscience-
based rehabilitation solutions. Northwestern University has a long and recognized history in the study of motor
control, motor disability and recovery, and neural reorganization; and in training the next generation of
movement and rehabilitation scientists (MRS) through the Northwestern University Interdepartmental
Neuroscience Program (NUIN) PhD program since 2009, with demonstrated success reflected in more than
20 graduates currently leading successful research careers in academia and industry. The proposed program
is built on this research and training record with the mission to train students with clinical and life/applied
science backgrounds and post-doctoral fellows with clinical backgrounds to become rehabilitation scientists in
basic, translational or clinical research. These scientists will have the ability to integrate knowledge from the
various disciplines involved in sensorimotor neurorehabilitation, including neuroscience, engineering and
clinical sciences. The training program will focus on four training goals: 1) to provide a thorough grounding in
the basic neurobiology of sensorimotor function and control, including translation of insights between animal
and human research models; 2) to learn fundamental engineering experimental methods for measurement
and analysis of neuronal and musculoskeletal sensory and motor function; 3) to facilitate knowledge sharing
in the clinical management of individuals with movement disorders between the post-doctoral and pre-doctoral
trainees; and 4) to provide professional development training to support future rehabilitation research career
success. The unique structure of the program, couples training of post-doctoral trainees with clinical expertise
with pre-doctoral trainees focusing on neuroscience. The program is the first of its kind to provide post-doctoral
research training of Doctors of Physical Therapy (DPT), an untapped cohort of prospective scientists that has
emerged in the contemporary age of science-based medicine and evidence-based practice. These DPT
candidates for post-doctoral slots will be drawn from research intensive Physical Therapy Programs across
the United States. Pre-doctoral trainees will be drawn from the NUIN-MRS program. The translational
interdisciplinary nature of the program will allow close interaction between clinical investigators and basic and
applied sciences investigators, providing a unique opportunity for training in translational research. We intend
to support a total of 12 pre-doctoral trainees and 5 post-doctoral trainees with NIH funding for up to two years
each. Additional institutional support is available in the form of tuition and stipend supplements for trainees and
diversity fellowships to support diversity recruiting efforts.

Public health relevance
Project Narrative The number of individuals with disabilities and the extent of the disabilities continue to increase with a clear impact on the need for developing better and more effective rehabilitation interventions. The proposed pre- and post-doctoral program will train rehabilitation scientists based on solid fundamental science principles combined with engineering methods to allow them to establish successful research programs that translate into effective rehabilitation interventions and more importantly, are transferred to the clinic.